A Multi-Site Mixed Methods Study of Methamphetamine Use in the Mountain West

7. Project Summary/Abstract
The goal of this proposal is to (1) examine patterns of methamphetamine (MA) use and related harms
(including MA use disorder and MA overdose) in the context of an entrenched and ongoing opioid use
epidemic, and (2) identify promising prevention, treatment, and harm reduction approaches for communities
disproportionately affected by drug-related harms. Our team has an established collaboration and research
infrastructure, and has conducted preliminary research that informs the current application. Using a
combination of structured epidemiological interviews, biological testing, and qualitative timeline follow-back
interviews, this proposal is designed to understand how MA and polydrug use patterns influence health
outcomes, with a focus on groups underrepresented in drug use research, especially now when research and
program efforts are almost exclusively confined to problematic opioid use. The aims of this proposal are:
1. To estimate prevalence of and identify risk and protective factors associated with current MA use, and
MA-related harms among people who use drugs.
a. Describe the frequency and quantity of MA use, and associations between MA use and other drugs,
including prescription (Rx) stimulants, opioids, and other polydrug use patterns. MA use will be
identified by self-report and by urine-toxicology screening.
b. Identify associations between MA use and (i) risk factors, (ii) protective factors, (iii) health and social
consequences (e.g.,self-reported HIV, HCV status, soft-tissue infections, OD, substance use disorder).
c. Examine moderating impact of socioeconomic status (SES), ethnicity, and stigma.
2. To qualitatively describe the experiences of and rationale for MA use, polydrug use, and progression to
misuse and dependence using lifetime drug use history interviews.
a. Describe patterns of initiation, transition between MA and other drugs, social and structural factors that
influence MA use (including Rx opioid and stimulant availability), social networks, and economic forces
that structure drug use and related harms.
3. To examine the feasibility and acceptability of promising prevention, treatment, and harm reduction
strategies for people who use MA.
a. Assess the feasibility and acceptability of potential biomedical interventions, such as
pharmacotherapies to treat MA use disorder that are currently in the clinical pipeline.
b. Assess feasibility and acceptability of harm reduction strategies for people who use MA.
This proposal responds directly to RFA-CD-21-002 Objective 2. It contains a detailed translation and
dissemination plan that will facilitate rapid implementation of actionable findings, and leverages a successful
existing multidisciplinary collaboration among investigators and community partners.

Public health relevance
8. Project Narrative Rates of opioid and methamphetamine-related harms (including overdose death) have increased dramatically in recent years. Nevada (NV) and New Mexico (NM) are two Mountain West states that have been disproportionately burdened by the opioid epidemic and also have high rates of MA use. We propose a multi- site mixed methods study in NM and NV to identify risk and protective factors for MA use and related harms, and identify promising prevention, treatment, and harm reduction strategy to reduce MA-related harm in the context of an entrenched and ongoing opioid overdose epidemic.